Improved Tools for Accessing Pain Following Fracture and Enabling Standardized Pain Phenotyping

ABSTRACT
Fractures are one of the most common injuries worldwide with The Lancet Global Burden of Diseases reporting
178 million new fractures and 445 million prevalent fractures in 2019.1 Delayed healing and non-union are
qualitative clinical diagnoses based on the persistence of a fracture line in longitudinal radiographs and pain/
instability with weight bearing. While robust global estimates of delayed/non-union are not available, the best
current data finds that 8-14% of fractures were readmitted for healing complications within 2 years post-injury.2
Delayed healing rates increase significantly if the fracture occurs in patients with high co-morbidity burdens such
as increased age, diabetes, or obesity.3,4 Current standard-of-care for these fractures is surgery to alter hardware
or implant bone grafts. There are currently no pharmacological agents approved to accelerate fracture healing.
As such, there exists an unmet clinical need for biologics that could stimulate bone regeneration in a non-surgical
delivery platform. The long-term goal of the Parent Grant is to develop and validate an injectable, biodegradable
nanowire delivery platform for local and sustained release of a “painless” nerve growth factor (NGF) isoform
to accelerate fracture healing in clinical scenarios of delayed healing. In support of the Parent Grant, we have
published that NGF acts on chondrocytes to promote molecular programs associated with endochondral
ossification5 and that NGF can be encapsulated into biomaterial platforms for controlled and localized delivery6.
Opioids are the standard of care for addressing post-fracture pain.7-11 The goal of this Pain Supplement is
to validate a novel technology with machine learning for measuring induced and spontaneous pain following
fractures. An innovative and central premise of the Parent Grant is the therapeutic use of a “painless” isoform of
NGF to promote fracture healing in murine models of delayed repair. Painless NGF results from a naturally
occurring point mutation in the wild type NGFβ sequence (NGFR100W) that enables binding to the TrkA receptor,
responsible for the trophic activity of NGF, but not to the p75 receptor responsible for pain.12 In our progress
report for the Parent Grant, we shared new data demonstrating that NGFR100W does not induce pain sensitization
at a dose 10-fold higher than NGFβ in the hindpaw of an unfractured limb. However, standard reflexive avoidance
assays were not reliable for induced pain when translated to a fractured limb. In this grant, we present the first
data using a novel technology, the BlackBox, coupled with DeepLabCutTM machine learning to monitor how
quantifiable behavioral endpoints of pain shift after bone fracture. We then utilize this technology to understand
perturbations to fracture pain by evaluating (Aim 1) induced pain in response to the injected NGF therapy, (Aim
2) changes in spontaneous pain in models of delayed fracture healing, and (Aim 3) the role of the NGF receptors
in modulating pain response. We accomplish these three Aims by establishing a new collaboration outside of
our current research base that has expertise in pain research (NOSI Goal B: Allan Basbaum Laboratory).

Public health relevance
PROJECT NARRATIVE The overall goal of this Pain Supplement is to validate novel imaging technology and machine learning tools for measuring pain following bone breaks, and then use these tools to understand mechanistic drivers of pain. We aim to develop robust and reliable protocols for measuring both (1) induced pain and (2) the resolution of chronic pain following fracture. We hypothesize that these tools can be used to distinguish the pain response to different therapies and in scenarios of delayed versus normal fracture repair, allowing us to understand significant biological factors that mechanistically lead to heightened pain sensation.